Modeling and design of complex RNA structures

PROJECT SUMMARY
The continuing discoveries of RNAs and their critical roles in cellular and viral machinery
are inspiring novel antibacterial, antitumor, antiviral, and genome-editing therapies
based on disabling, manipulating, and repurposing the RNAs involved. Unfortunately,
our poor biophysical understanding of `how RNAs work' is slowing the development of
these potentially life-saving efforts. A critical bottleneck has been the inapplicability of
crystallography, NMR, phylogenetic analysis, and biochemical methods to determine the
partly ordered conformations of non-coding RNAs in all their functional states. To
address this bottleneck, we bring together biophysical modeling, electron microscopy,
high throughput biochemical/sequencing experiments, machine learning, wet-lab-
integrated crowdsourcing, and a wide collaborative network. Current projects that
exemplify our approach involve the COVID-19 pandemic. With our Ribosolve hybrid
structure determination pipeline, we are discovering that numerous segments of the
SARS-CoV-2 RNA genome form well-defined 3D structures whose targeting by
antisense oligonucleotides inhibits viral replication. In the OpenVaccine challenge, we
are developing highly structured COVID-19 mRNA vaccines with sufficient in vitro
stability to enable world-wide shipping of mRNA in prefilled syringes. This COVID-19
research has benefited from our agile approach and the flexibility allowed by MIRA
support; many of the computational and experimental methods we use now did not exist
before the pandemic. Because RNA is so fundamental to life, tackling many of science's
further `big questions' in human disease could be accelerated if we could visualize and
design any RNA. My lab seeks to create the RNA computational and experimental
foundation needed to get all of us there in upcoming years.

Public health relevance
PROJECT NARRATIVE RNA molecules play fundamental roles in transmitting and regulating genetic information in all living systems, including disease-causing bacteria, RNA viruses like HIV and SARS-CoV-2, tumor cells, and our own brains and bodies. New potentially life-saving therapies and vaccines that target or repurpose these RNAs are being hindered by our imperfect understanding of how RNAs fold into intricate 3D structures. Our work aims to develop new 3D-structure-focused tools that are missing in current RNA biomedical research.